GENERAL CLINICAL RESEARCH CENTER

The General Clinical Research Center is the major setting for clinical investigations of the faculty of the Medical College of Wisconsin. Major current areas of research include: 1) the natural history and pathophysiology of hypersensitivity lung disease; 2) diabetes and the hormonal regulation of carbohydrate metabolism including the interaction of insulin, glucagon, growth hormone, estrogens, prolactin and other hormones; 3) studies of obesity (morphologic classification, fat cell morphology and metabolic and molecular basis of insulin resistance); 4) evaluation of the normal motor function of the esophagus, function and control of the lower esophageal sphincter (LES) and pathophysiology and treatment of reflux esophagitis; 5) pathogenetic factors in patients with calcium-containing kidney stones; 6) regulation of phosphate and vitamin D metabolism (),25-(OH)2-D) in health and in calcium stone formers; 7) mechanisms of intestinal absorption, pathogenesis of diarrhea, gastrointestinal function in diabetes mellitus, and mechanism of gonadal dysfuncton in hepatic cirrhosis, 8) therapy of aplastic anemia and polycythemia vera; 9) evaluation of hypothalamic pituitary function in pituitary disorders and in obesity; 10) therapy of traumatic myelopathy and radiculopathy; 11) detection and significance of new leukemic antigens; 12) early manifestations of Fabry's disease in kidney and intestine; and 13) significance of particulate matter in joint fluid and the use of new, nonsteroidal, anti-inflammatory agents in the treatment of rheumatoid arthritis.